Exploring the function of a novel tyrosine kinase like (TKL) protein in Toxoplasma endodyogeny

PROJECT SUMMARY/ABSTRACT
Toxoplasma gondii is an important human pathogen that divides by a unique mode of cell division
called endodyogeny that is quite distinct from binary fission that occurs in mammalian cells. Since
Toxoplasma division is divergent from higher eukaryotes, a better understanding of this complex
process and identification of its key components and their mode of regulation would potentially
open doors for selective strategies to disrupt infection. TgTKL4 is a member of tyrosine kinase
like (TKL) family protein in Toxoplasma that localizes to parasite cytoplasm with its expression
mainly confined to synthesis (S), mitosis/cytokinesis (M/C) phases of the cell cycle. Interestingly,
loss of this kinase causes defects in cell division that results in misshapen parasites with
compromised fitness and attenuated virulence. Specifically, TgTKL4 null mutants with abnormal
morphology display significant defects in in vitro propagation suggesting loss of this kinase affects
one or more stages of Toxoplasma lytic cycle. Since TgTKL4 is a cell-cycle regulated kinase and
parasites deficient in this enzyme show abnormal shape, we hypothesize that this kinase is a part
of the signaling network that dictates parasite morphology during endodyogeny. To further
understand the role of this novel TKL kinase in parasite replication, we propose to: (1) Identify
substrates of TgTKL4; and (2) Determine the role of TgTKL4 in Toxoplasma endodyogeny. Thus,
our proposed work will help us understand the precise function of TgTKL4 and signaling network
associated with this kinase during cell division that determines parasite morphology.

Public health relevance
PROJECT NARRATIVE Toxoplasma gondii is an important human pathogen that causes life threatening illness in immunodeficient individuals, abortion in pregnant woman and blindness in newborn children. Our proposed studies aim to define the function of a novel kinase that plays an important role in parasite division. This research will reveal role of this kinase in Toxoplasma cell division and also identify it’s signaling network which in the long-term could open doors for new therapeutics.